Regulation of metabotropic glutamate receptor activity by protein/protein interactions

PROJECT SUMMARY
Metabotropic glutamate receptors are G Protein-Coupled Receptors (GPCRs) that serve as critical regulators
of neurotransmitter release. Within the mGlu family, the three widely expressed members of the group III mGlu
receptor subfamily (mGlu4, 7 and 8) modulate glutamate and GABA release from presynaptic terminals throughout
the brain. Recently, it has been shown that the group III mGlu receptors are “anchored” at specific presynaptic
locations by the postsynaptic expression of laminin proteins termed Extracellular Leucine Rich Repeat and
Fibronectin Type III Domain Containing 1 and 2 (Elfn1 and Elfn2). Of the group III receptors, mGlu7 and Elfn1
have been reported to form a critical pairing, as mutations in each protein in humans are correlated with ADHD
and seizures. Additionally, both Elfn1 and Grm7 knockout mice exhibit cognitive and motor impairments, blunted
responses to amphetamine, and seizures that develop with a similar developmental time course.
mGlu7/Elfn1 interactions localize the receptor to the active zones of glutamatergic pyramidal cell synapses
onto somatostatin-containing GABAergic interneurons (SST-INs) in the hippocampus and prefrontal cortex
(PFC). Dysfunction of SST-INs interneurons has now been described in numerous diseases such as
schizophrenia, autism and epilepsy; therefore, the mGlu7/Elfn1 interaction in SST-INs is in a position to fine tune
inhibitory synaptic responses onto pyramidal cells to provide distinct circuit-level control of hippocampal and
cortical networks. In vitro, Elfn1 allosterically inhibits agonist-mediated activation of the group III mGlu receptors.
Using a system in which we have co-cultured cells expressing mGlu7 with cells expressing Elfn1, we have now
identified a positive allosteric modulator (PAM) and a negative allosteric modulator (NAM) of mGlu7 that are no
longer active when Elfn1 is present; in contrast, other PAMs and NAMs exhibit activity at mGlu7 regardless of
the presence of Elfn1. In the current application, we will test a suite of control agonists, PAMs, and NAMs for
activity at mGlu7 with and without Elfn1 and perform analogous studies with mGlu4/Elfn1, mGlu8/Elfn1 and
mGlu7/Elfn2 to understand compound specificity. We will then prepare the mGlu7/Elfn1 assay for HTS and
conduct a pilot screen of an existing 1,000 compound collection of mGlu7 receptor modulators to identify new
activators and antagonists to probe this interaction. Finally, we will test the hypothesis that the pharmacological
profiles we observe in vitro in the presence and absence of Elfn1 will also be seen in a native tissue preparation
at SST-INs. It is anticipated that these small molecules will assist in understanding the basic biology of
mGlu7/Elfn1, create novel assays to assess GPCR signal bias, generate highly selective tools to specifically
modulate SST-INs versus other types of interneurons, and could eventually represent a highly selective way to
modulate mGlu7 activity only at specific synaptic locations.

Public health relevance
PROJECT NARRATIVE Interactions of the laminin protein Elfn1 and metabotropic glutamate receptor 7 (mGlu7) result in transsynaptic localization of the two proteins and mutations in each gene cause similar phenotypes in terms of attentional deficits and seizures in people and mice. We have identified several mGlu7 allosteric modulators that are no longer active at mGlu7 when complexed with Elfn1. We propose here to test the hypothesis that our internal mGlu7 modulator collection contains additional compounds that differentiate at the level of Elfn1 and to test the hypothesis that the differential pharmacology observed for modulators in the presence and absence of Elfn1 will be manifest at synapses in the cortex.